Mechanistic and Structural Insights into Intraflagellar Transport in Leishmania

Project Summary
Trypanosomatid parasites are responsible for several human diseases including Chagas disease
(Trypanosoma cruzi), African trypanosomiasis (Trypanosoma brucei), and leishmaniasis (various Leishmania
species). These parasites critically depend on a single flagellum for motility, environmental sensing, and cell
attachment. Disruptions in flagellar motility or intraflagellar transport (IFT) impair the ability of the parasite to
survive in insect vectors or mammalian hosts. The flagellum is therefore essential for the parasite’s survival
and pathogenicity, making IFT a potential therapeutic target. IFT involves the movement of cargo-laden
megadalton complexes called IFT trains along the outer face of doublet microtubules within flagella. Recent
cryo-electron tomography studies have elucidated the molecular architecture of IFT trains in green algae, but
the conservation of IFT train structure, and their interactions with different cargo adaptors and the doublet
microtubule tracks they travel along, remains unclear. We propose to use a genetically tractable Leishmania
species, Leishmania tarentolae, as a model organism to address these questions. We propose a
multidisciplinary approach that combines structural biology, live-cell imaging, proteomics, and high-throughput
bioinformatic screens. Successful completion of this work will reveal the conserved and trypanosomatid-
specific features of Leishmania IFT, identify new adaptor proteins that link polyubiquitinated proteins to IFT
trains for export from flagella, and determine whether microtubule-associated proteins that bind the surface of
doublet microtubules regulate IFT. Given that IFT is essential for the pathogenicity of trypanosomatids, this
research may identify targets for the development of novel therapies for diseases that put millions at risk of
infection globally.

Public health relevance
Project Narrative Trypanosomatid parasites, including Leishmania species, cause several devastating human diseases that threaten millions of people globally. The pathogenicity of these parasites is dependent on a single flagellum and the process of intraflagellar transport responsible for its formation. This proposal aims to elucidate mechanisms of intraflagellar transport in Leishmania, to provide fundamental insights into the biology of flagella and identify potential targets for novel therapeutic interventions against leishmaniasis.